HIV and Liver Disease Conference

Abstract
Liver disease is major contributor to morbidity/mortality among those with HIV. The etiologies of
liver disease include viral hepatitis (A through E) as well as drug-induced liver toxicity. Direct
and indirect effects of HIV on stellate cell activation, and on alteration of the cytokine milieu in
the liver contribute to injury. Research and information sharing remain fragmented along
specialty lines. In an ongoing effort to improve communication, stimulate the research agenda,
and develop new productive collaborations, we propose the continuation of a series of
conferences on HIV and Liver Disease. The proposed conferences will take place over a three
day period in 2020, and 2022 which will bring together leading experts in the field including
those in Infectious Diseases, Hepatology, Addiction Medicine, Pharmacology and Psychiatry. In
addition, young investigators and trainees will be encouraged to attend via a scholarship
mechanism supported by this grant. Meeting outcomes include provision of continuing medical
education credit, development of a published manuscript on the subject, and possibly the
creation of a web-based educational site. Particular attention will be paid to development of new
research concepts and establishment of collaborative associations by participants. A new
mentoring plan for trainee scholarship recipients will be introduced.

Public health relevance
Project Narrative Liver disease is an important health problem among people infected with the human immunodeficiency virus (HIV). This proposal describes continuation of a multidisciplinary conference designed to bring together key U.S. and international experts in the field to review the most current information and to develop research strategies that will reduce the health impact of liver disease in these patients.